TTD

A Rehemtulla and KR Oldham will serve as Project Lead and Co-Lead, respectively, for the TTD Core.
This Core will provide training and dissemination resources for use by a national and international audience
to bridge the gap between engineering and biology in the emerging field of in vivo microendoscopy.
Opportunities will be provided for CP/SP users, Center personnel, and outside researchers to become next
generation investigators in in vivo imaging. The Core will provide training and education in basic concepts.
Participants will be trained to 1) understand capabilities and limitations of microendoscopy, 2) identify
parameters for specific applications, and 3) use operating software to control scan mechanisms, collect
images, and interpret data. Education will be provided through hands-on training, workshops, academic
courses, mentorship, seminar series, and local conferences. Dissemination through CP/SPs will accelerate
broad acceptance of these technologies to advance in vivo imaging.
An integrated curriculum will be developed to incorporate fundamentals in microsystems technologies,
microendoscopy, and computational tools. Training opportunities will be available on-line and in person.
Educational materials will be prepared for beginners ranging to advanced users. In addition to didactic
lectures, trainees will attend tutorials on how to commercialize microsystems technologies to leverage potential
for mass device production. Early stage trainees will have an opportunity to be mentored by Center faculty in
small cohort of students. The ultimate goal is to provide mentorship experiences to motivate further training
and a scientific career in microendoscopy. Hands-on training will be offered to CP/SP users to gain experience
with use of microendoscopes and operating software to perform in vivo imaging in small animal models and in
the clinical setting. Training will be designed primarily for CP/SP personnel, Center users, and outside
investigators, and will be made available to a broad audience, including beginners and advanced users.
A multi-faceted program will be developed to disseminate Center imaging technologies. A robust Center
website will be developed to provide links to all online training opportunities. Outside investigators will have
access to experimental protocols, SOPs, imaging system availability, and open source software, including
nTracer, nGuage, and MiCV. Updates on operating software, new computational tools. In vivo images will be
stored in standard formats to facilitate broad dissemination to outside investigators who want to validate the
results. These image can be processed using common software packages, such as MATLAB and NIH Image
J2. Center technologies will be commercialized via a start-up to provide technical support, software
development, hardware prototyping, and technology transfer for pre-clinical and clinical imaging using
microsystems devices, microendoscope, and software. New initiatives for dissemination will include a special
journal issue on microendoscopy, a joint P41 conference, and social media.